Role of SMARCA5 in Glioblastoma

Glioblastoma is an incurable primary brain tumor. Glioma cells lie along a continuum, with glioma
stem cells (GSCs) at one end and differentiated glioma cells (DGCs) at the other end. GSCs have
a high capacity for self-renewal and are highly resistant to standard treatments. They therefore
play critical roles in disease progression. DGCs, on the other hand, comprise the bulk of tumor
cells and are more sensitive to treatments. Forcing GSCs to differentiate may therefore render
GBM less aggressive, resulting in improved patient survival. While differentiation therapy is used
for some cancers, it has not yet worked successfully in GBM. Obstacles lie in finding suitable
targets to force GSCs to differentiate yet not impact normal stem/progenitor cells. The stem cell
state is maintained through the expression of stem-cell lineage genes and repression of genes
involved in differentiation. In GSCs, chromatin is locked in a conformation such that expression
of genes that specify the stem cell state are open and accessible to transcription factors, whereas
expression of genes involved in differentiation are in a closed conformation and inaccessible.
Chromatin remodeling complexes play key roles in regulating the chromatin landscape and
expression of genes involved in cell state. Our strategy is to tip the balance between co-activator
(e.g. SWI/SNF) and co-repressor (e.g. ISWI/CHD) complex activity. As a result, chromatin
accessibility and conformation are altered to facilitate expression of pro-differentiation genes and
reduce expression of stem cell maintenance genes. The result is the conversion of highly
malignant GSCs into less aggressive DGCs. In this proposal, we identify the ISWI complex
component SMARCA5 as a therapeutic target. Our pilot studies support that inhibition of
SMARCA5 forces GSCs to differentiate. Further, we have developed a first-in-class and brain-
penetrant inhibitor of SMARCA5 that extends animal survival in GSC-derived orthotopic models
of GBM. This inhibitor appears safe for normal but not malignant cells. We hypothesize that
SMARCA5 regulates GSC cell state, and that its targeting in GSCs will facilitate their
differentiation to improve tumor control. We will assess the role of SMARCA5 in regulating GSC
maintenance and tumorigenic potential. We will also determine its role in shaping the chromatin
landscape and the expression of genes that regulate cell state. These studies will provide
mechanistic understanding of cell state regulation and offer a strategy of differentiation therapy to
improve GBM control. Preclinical studies with our first-in-class SMARCA5 inhibitor will facilitate
its clinical translation.

Public health relevance
PROJECT NARRATIVE Glioma stem cells are a highly malignant population of cells that contribute to glioblastoma recurrence. This work will reveal a novel mechanism by which a chromatin remodeler regulates cell state and provides a strategy for forcing glioma stem cells to differentiate into less aggressive cells, thereby improving tumor control. If successful, the findings of this study can be translated to improve treatment for glioblastoma.